Relationship Between Cortical Planning Activity and Disordered Spoken Interaction

Project Summary
While considerable progress has been made investigating the neural mechanisms underlying speech
articulation, less is known about how the brain plans spoken language. Efficient, rapid speech planning is critical
for enabling turn-taking interactions during conversation. Planning dysfunction has been linked to several
disorders, including Parkinson disease (PD). To investigate the neural foundations of this key cognitive process,
the Long lab recently used electrocorticography (ECoG) to identify a compact frontal network that is selectively
active during the planning of both structured and spontaneous spoken exchanges. A central component of this
network is the caudal middle frontal gyrus (cMFG), which represents a novel language planning area. The study
also used direct electrical stimulation to perturb cMFG which caused preparatory deficits such as response errors
and reaction times. These results indicate that cMFG is a critical speech-related planning region, yet raise
important clinical questions. Do neuropathologies that impact patients’ speech also affect cMFG function? And
how do the interventions we use to treat these diseases affect cMFG? Thus, dissecting cMFG function at a
neural circuit level will yield fundamental insights into the neural mechanisms of language generation and its
relationship with different neuropathologies. In this proposal, I therefore focus on the relationships between
neuropathology, speech planning, cMFG function, and neuromodulatory treatment in patients with PD by utilizing
the access provided by awake insertion of deep brain stimulation (DBS) electrodes. PD is a devastating
neurodegenerative disorder caused by the loss of dopaminergic neurons. In addition to motor symptoms such
as bradykinesia and tremor, PD patient exhibit speech dysfunction. The mechanism speech deficits in PD are
poorly understood, but preliminary work implicates impaired speech planning. Furthermore, the effect of DBS
therapy, a mainstay of PD treatment that significantly improves motor symptoms, is unclear – evidence
demonstrates that only a subset of patients experiences long-term improvement in speech function despite an
improvement in the motor functions required for speech such as laryngeal motion, suggesting a limited ability to
improve the higher-order process of speech planning. Here I will leverage the diversity of patients at our center
undergoing the placement of DBS electrodes to compare cMFG function in patients with PD and other
neuropathologies, such as cervical dystonia and essential tremor, that do not significantly affect speech planning,
to determine the effect of PD and DBS therapy on cMFG function and clinical speech function in PD patients. I
will therefore test the central hypothesis that cMFG planning activity is perturbed in PD, and a predictor of
patients’ speech improvement with DBS therapy.

Public health relevance
Project Narrative This project seeks to elucidate the neural mechanisms underlying speech planning and speech planning deficits in Parkinson’s disease (PD) by performing high-resolution electrophysiologic recordings from a new region of interest in the creation of speech, the caudate middle frontal gyrus (cMFG), in patient-volunteers undergoing awake deep brain stimulation (DBS) electrode implantation surgery. We will explore the impact of PD and of DBS therapy on the function of cMFG and speech performance intraoperatively and longitudinally. Ultimately, we will advance our understanding of how speech is planned, how PD impacts that process, and how we can predict which patients will respond to DBS.